Medical Marijuana, Emerging Adults, and Community: Connecting Health and Policy

PROJECT SUMMARY/ABSTRACT
The rising number of individuals with legal access to marijuana for medical and/or recreational use is
arguably the most profound change in drug policy in the past 20 years given the potential impact on public
health. California, one of 28 states that authorized marijuana for medical use since 1996, became the eighth
medical marijuana state to legalize marijuana for recreational use following the passage of the Adult Use of
Marijuana Act (AUMA) in 2016. No research has studied the real-time transition from a medical to a
recreational environment and its impact on young adult marijuana users since states began legalizing
marijuana for recreational use in 2012. Furthermore, no study has examined the impact of legalization for
recreational use on 18 to 20 year olds – a group eligible for medical use but prohibited from recreational use
in all legal states. Our long-term goal in this renewal of a current R01 is to inform public policy with findings
on safer and controlled use of marijuana among young adults in an environment where marijuana is legal
for recreational use. Our objective here is to determine the impact of legalization on young adult marijuana
users (18 to 30 year olds) by continuing the study of a cohort of young adults – 210 medical marijuana
patients (MMP), 156 non-patient marijuana users (NPU) - recruited in Los Angeles, CA in 2014-15 while
also enrolling a new cohort of 150 18 to 20 year old marijuana users. Our central hypothesis is that
legalizing marijuana for recreational use will result in increased marijuana use, other drug use, and risk
behaviors among young adults, but this increase will vary by patient status (MMP vs. NPU) and orientation
towards marijuana use, i.e., medicinal vs. recreational. Our rationale for the proposed research is that
renewing a current R01 will offer the unique opportunity to: analyze marijuana use, other drug use, and risk
behaviors on a cohort of young adult marijuana users continuously collected both before and after
legalization in California; and recruit a new underage cohort of marijuana users for comparative purposes.
Guided by preliminary data from the current R01, the central hypothesis will be tested by pursuing three
specific aims: 1) Determine the impact of marijuana legalization on trajectories of marijuana use, including
high-potency forms, e.g., dabs, edibles, among MMP and NPU (aged 21 to 30); 2) Determine the impact of
marijuana legalization on patterns of other drug use and risk behaviors among medicinal and recreational
users (aged 21 to 30); and 3) Determine the impact of marijuana legalization on attitudes and patterns of
marijuana use among a newly recruited cohort of underage young adults (aged 18 to 20). The approach is
innovative because it uses an interrupted time series design to study the effects of legalizing marijuana on
young adults, includes both legal and non-legal recreational users, and includes medicinal orientation of
marijuana use among recreational users in a fully legal context. The proposed research is significant since
the public health impact of legalizing marijuana for recreational use among young adults is unknown.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because determining the impact of legalizing marijuana on the health of emerging adults, including risks and benefits, may lead to modifications of drug policies in Los Angeles and elsewhere. Thus, the proposed research is relevant to the part of NIH's mission that pertains to improving the health of the U.S. by understanding mental, addictive, and physical disorders.